Targeting NF-kB in Atherosclerosis

? DESCRIPTION (provided by applicant): Atherosclerosis is a slowly progressing chronic inflammatory disease of the medium and large arteries that is responsible for high mortality rates. Consequently, developing new effective strategies to prevent or cure atherosclerosis will profoundly impact human health care. Activation of vascular ECs (VECs) is crucial for the initiation and progression of atherosclerosis and our long-term research goal is to define the signals that control VEC activation, as this will reveal novel targets for new anti-inflammatory drugs. A central signaling mechanism in atherogenesis is activation of the NF-κB family of transcription factors. In the current model of NF-κB activation, signaling occurs via classical or non-canonical pathways, resulting in the activation of distinct NF-κB species that control discrete sets of pro-inflammatory genes. Genetic studies strongly implicate classical NF-κB in VECs in atherogenesis. However, as detrimental immunological side effects of small molecule IKKß inhibitors present a major roadblock to systemic clinical targeting of this crucial pathway, we propose to test the hypothesis that selective pharmacological inhibition of VEC-intrinsic classical NF-κB will prevent atherogenesis and/or reduce established atherosclerotic plaques. To test this hypothesis, we will utilize our recently developed innovative strategy to selectively deliver a classical pathway inhibitor to activated VECs in vivo and we will determine how this approach affects both the development and resolution of atherosclerosis in mice (Aim 1). While IKKß-driven classical NF-κB in VECs appears to play a key role in atherosclerosis, the function of IKKα is unexplored. Therefore, we generated mice specifically lacking IKKα in VECs (IKKαVEC) that we have crossed with ApoE-/- animals (IKKαVEC-E). Notably, our preliminary findings indicate that atherosclerosis is reduced in IKKαVEC-E mice. However, as we also found that IKKα controls both non-canonical NF-κB activation and a novel alternative pathway that unexpectedly activates classical NF-κB species, we will determine if either or both of these IKKα-driven pathways function in atherogenesis (Aim 2). Finally, while developing an in vivo model to assess epithelial cell-intrinsic IKKα function, we made the groundbreaking discovery that lymphatic function is compromised in mice that specifically lack IKKα in lymphatic epithelial cells (LECs) (IKKαLYVE1 mice). While lymphatic vessels appear normal in IKKαLYVE1 mice, lymph node (LN) development is compromised. As local lymphatic vessels are implicated in later stages of atherogenesis, we hypothesize that non-canonical NF-κB signaling in LECs will influence disease progression through its effects on lymphatic function and will test this hypothesis using our novel genetic model (Aim 3). Accomplishing our aims will provide new understanding of the roles of VEC- and LEC-intrinsic NF-κB in disease progression and the potential therapeutic value of selectively targeting classical or non-canonical NF-κB signaling in atherosclerosis patients.

Public health relevance
PUBLIC HEALTH RELEVANCE: Atherosclerosis is a chronic inflammatory disease of the medium and large arteries that has a high mortality rate in the United States and other western societies. We will use novel state-of-the-art genetic and pharmacological approaches to define the cellular signals in blood and lymphatic vessels that play critical roles in the development of atherosclerosis. Importantly, we will determine whether blocking these key signals will reduce or cure atherosclerosis in mice with established disease. Our studies will directly impact public health, as they will provide crucial insight for future therapeutics designed to inhibit the major pro-inflammatory signals driving atherosclerosis.